DEVELOPMENT OF AN AUTOMATED CARTRIDGE-BASED BREAST CANCER DETECTION ASSAY- AN ACADEMIC-INDUSTRIAL PARTNERSHIP

Abstract.
Work from the past 30 years has established the importance of epigenetic mechanisms of silencing of tumor
suppressor genes. DNA methylation has emerged as one of the most common and conserved methods of
epigenetic silencing, causing loss of expression of thousands of genes. Epigenetic alterations are significant
drivers of tumorigenesis in all cancer types. Work from our group and others over the last 25 years has firmly
established that specific genes that become aberrantly methylated uniquely, early, and frequently in breast cancer
provide excellent biomarkers for breast cancer detection, prediction of response to therapy, and prognostication
of the course of the disease. In the parent grant, we have proposed a five-gene panel for accurate detection of
breast cancer in fine needle aspirates of suspicious breast lesions. Among them, Zinc finger (ZF) 671 (ZNF671)
is a powerful detection marker, since it is frequently methylated in breast cancer and a variety of other carcinomas,
but not in normal tissues. However, literature on its function is sparse; little is known about its upstream regulators
or its downstream targets. For this supplement, we will investigate the pathways through which ZNF671
functions. We hypothesize that ZNF671 will behave as a tumor suppressor protein in breast cancer cells, both in
cultured cells and in vivo. Based on the function of other ZNF proteins as embryonic differentiation factors, we
propose that loss of ZNF671 will lead to dedifferentiation, increased stemness, and acquisition of aggressive
neoplastic properties by cancer cells. To test this hypothesis, we proposed two specific aims. In Aim 1, we will
study the phenotypic and molecular changes brought about by overexpression and knockout (KO) of ZNF671 in
4 breast cancer cell line models. In Aim 2, since the ability for unlimited replication is dependent on the stem cell
population, we will test whether the presence or absence of ZNF671 influences the population of stem cells in
breast cancer cells both in vitro and in vivo. Through this proposal, the baccalaureate candidate will learn the
scientific process, and that of interpreting and reporting results. She will learn a variety of techniques to analyze
biological and molecular changes brought about by overexpressing or knocking down the expression of ZNF671
in breast cancer cells. Microarray analysis of breast tumor cells with KO of ZNF671, its data analysis, and
validation of gene expression by RT-qPCR will provide a wealth of data on downstream effector pathways of
ZNF671. To achieve career developmental goals of the candidate, a program of training and career development
opportunities through coursework, talks, networking, peer mentoring, shadowing and conference attendance and
presentation has been described. At the completion of this supplement, the candidate will be fully equipped to
compete for entry into a MD, PhD program.

Public health relevance
Project narrative. The intent of this proposal is to provide the baccalaureate candidate with the assets needed to render her highly competitive for a career in academic medicine. With this in mind, we have proposed, 1) a study of the function of ZNF671, a gene frequently methylated in breast cancer, that will provide a solid training in laboratory investigation, 2) courses that will bolster her current understanding of cancer and treatment strategies, and, 3) assistance in career development through conferences, mentorship, communication and networking. This three- pronged approach will provide the candidate with the all the tools necessary for success.